Mechanisms of Endosomal Dysfunction at Synapses in A-Synuclein Pathology

ABSTRACT/SUMMARY
Synucleinopathies, including Parkinson’s disease (PD) and Dementia with Lewy Bodies (DLB), are
neurodegenerative diseases characterized by the abnormal aggregation of α-synuclein. Furthermore, it is well
known that α-synuclein exists in multiple structural forms (i.e., monomers and oligomers) that contribute to
neurotoxicity by distinct mechanisms. While there is substantial evidence that accumulation of α-synuclein
broadly impairs synaptic vesicle endocytosis, the effects of distinct α-synuclein species on synaptic endosomal
trafficking are largely unknown. The proposed studies will be the first to investigate in detail how accumulation
of different oligomeric α-synuclein species affect endosomal trafficking at vertebrate synapses and the
underlying cellular and molecular mechanisms. Using the lamprey synapse model, a classical vertebrate
model, we can deliver precise amounts of purified -synuclein species directly into synapses. This allows us to
independently test the effects of different -synuclein species on presynaptic ultrastructure and function. Our
preliminary studies suggest that excess monomeric -synuclein impairs endosomal trafficking, as shown by a
reduction in the number of synaptic vesicles and concomitant increase in the number of atypical large vesicles,
reminiscent of endosomes. This provides an excellent model for the proposed studies. In Aim 1 (K99), we will
determine how monomeric human -synuclein affects endosomal trafficking at synapses. In Aim 2 (R00), we
will determine how oligomeric human -synuclein contribute to -synuclein-mediated endosomal dysfunction at
synapses. The focus will be on different oligomeric -synuclein species including dimers, small oligomers and
larger oligomers from PD/DLB human brains. These studies will provide critical understanding for the
development of therapies for improving synaptic function in synucleinopathies.

Public health relevance
PROJECT NARRATIVE Aggregation of α-synuclein at synapses, the functional contacts between neurons, has been linked to cognitive deficits and dementia in Parkinson’s disease and Dementia with Lewy Bodies. The proposed studies will provide insights into the early events and mechanisms leading to synaptic dysfunction in α-synuclein-related diseases. Understanding these mechanisms will help advance the development of therapies aimed at improving synapse function in neurodegenerative diseases.